HIV, Sleep, Nocturnal Non-dipping, and Cardiovascular Disease: a Tanzanian Cohort

ABSTRACT: The incidence of cardiovascular disease (CVD) in people with HIV (PWH) is ~2.5-fold higher
than among HIV-uninfected adults of similar age. HIV-attributable CVD risk is highest in Africa.
Ambulatory blood pressure (ABP) monitoring with a portable cuff worn for 24 hours provides mean daytime
and nighttime blood pressures and detects abnormalities in the diurnal variation of blood pressure such as
nocturnal non-dipping, which is defined by the absence of the 10% usual fall (dip) in blood pressure at night.
ABP more accurately predicts CVD events than office blood pressure. Elevated nighttime blood pressure and
non-dipping may contribute to the excess CVD risk in PWH. Small, cross-sectional studies suggest that non-
dipping is more common in PWH and may be associated with CVD. The long-term goal is to reduce CVD
morbidity and mortality in PWH. The study objectives are to 1) compare the time course of non-dipping and
resulting preclinical CVD in PWH vs. HIV-uninfected adults and 2) to identify potential pathophysiologic
pathways that could be targets for future intervention. We propose a comparative cohort study of PWH and
HIV-uninfected adults with repeated measures of ABP, sleep, SNS activity and preclinical CVD to be
conducted in an established cohort of 500 PWH and 500 HIV-uninfected adults in Tanzania.
Aim 1: To determine the prevalence of confirmed non-dipping and its association with incident
preclinical CVD after 36 months in a cohort of 500 PWH on stable ART and 500 matched HIV-uninfected
adults (age >30 years) in Tanzania. ABP will be performed at baseline and then repeated at 1 month.
Preclinical CVD will be quantified at baseline and after 18 and 36 months. Incidence of CVD events will also be
monitored. We will also examine other ABP abnormalities in relationship to preclinical CVD.
Aim 2: To determine the temporal relationship between sleep disorders, SNS activity and non-dipping
and whether this differs by HIV status or gender. We will quantify sleep and SNS activity at baseline and
after 18 and 36 months on all participants. We will also investigate the renin-angiotensin system, insulin
resistance and chronic inflammation as potential pathways leading to non-dipping. We will also compare
temporal trends in sleep and SNS activity between PWH and HIV-uninfected adults.
The proposed research will be the first longitudinal study of ABP and sleep disorders in Africa and will directly
inform HIV-specific and general guidelines. We will also lay groundwork for a mechanistic clinical trial to test a
novel, low-cost strategy targeting ABP abnormalities to prevent CVD in PWH.

Public health relevance
NARRATIVE: Cardiovascular disease (CVD) including heart failure, stroke, and myocardial infarction are leading causes of morbidity and mortality in people with HIV worldwide with the highest HIV-attributable CVD risks observed in Africa. Elevated blood pressure at nighttime and poor sleep may contribute to this increased risk of CVD in people with HIV. Our cohort study in Tanzania will be the first to investigate the relationship between nighttime blood pressure, poor sleep, and the onset of CVD in people with HIV and our research findings will inform the design of prevention and treatment interventions to prevent CVD in people with HIV in both Africa and in the United States.